Cooperation of the TAM and Abl family kinases in therapeutic resistance in HNC

PROJECT SUMMARY
One of the most deployed molecular targeting agents in the treatment of head and neck cancer (HNC) is the
Epidermal Growth Factor Receptor (EGFR)-targeted monoclonal antibody cetuximab (CTX). Cetuximab is a
central component of the first-line EXTREME regimen and in combination with radiation therapy and is the only
drug that exhibits efficacy in both locally advanced and recurrent/metastatic HNC. Although many HNC
patients see CTX over the course of their cancer therapy, research over the past decade has revealed that
many patients that do respond initially will eventually become refractory to CTX.
To identify drivers of CTX resistance (CTXR) in HNC, our lab utilized HNC human tumor specimens,
patient-derived xenografts (PDXs) and a series of acquired and intrinsically resistant in vitro and in vivo model
systems. This work led to the identification of the receptor tyrosine kinase (RTK) AXL as a central driver of
CTXR. To define the molecular mechanisms of how AXL signaling leads to CTXR, three tyrosine residues of
AXL (Y779, Y821, Y866) were mutated and mapped for their sensitivity to CTX. Both in vitro and in vivo
analysis revealed that 1) CTXR emanates from signaling from Y821 of AXL via the c-Abl kinase, 2) pre-clinical
modeling (PDX) indicated that the combination of CTX plus imatinib (IMT), a c-Abl kinase inhibitor, lead to
complete tumor regression without recurrence in HNC models and 3) preliminary data for this application
suggests that AXL, via Y821, sequesters c-Abl in the cytosol and prevents it from moving to the nucleus, which
is induced by IMT, to promote apoptosis. Collectively, we hypothesize that AXL plays a critical role in CTXR by
sequestering c-Abl in the cytosol and that therapeutic targeting c-Abl in combination with CTX will lead to
profound responses in HNC patients. We plan to conduct this interdisciplinary project, spanning from basic
biology to a pilot clinical trial through the three following aims: 1) To investigate if a) cytoplasmic sequestration
of c-Abl is responsible for AXL mediated CTXR and if b) if AXL and c-Abl association is a predictive biomarker
of CTX response, 2) determine if targeting EGFR and c-Abl simultaneously in CTXR PDXs can enhance and re-
sensitize to CTX, and 3) To perform a pilot window-of-opportunity study of CTX plus imatinib in patients with
recurrent or metastatic HNC. Ultimately, our goal is to improve treatment outcomes for HNC patients.
Successful pursuit of these investigations has the potential to significantly improve and refine current HER
family-centric therapeutic approaches in HNC by understanding the molecular mechanisms of how Axl and
c-Abl impart CTXR. In addition, this project has high significance by repurposing two FDA approved drugs in a
new cancer setting to improve outcomes. Collectively, this work will impact future clinical treatment
paradigms and identify patients most likely to benefit from targeting EGFR and c-Abl in HNC.

Public health relevance
PROJECT NARRATIVE The only approved molecular targeting agent in the treatment of head and neck cancer (HNC) is cetuximab, an antibody directed against the EGFR. The vast majority of patients are either intrinsically resistant or acquire resistance to this promising agent. We have identified the receptor tyrosine kinase AXL mediates resistance through the c-Abl kinase and together function as a major driver of resistance. We will investigate how AXL and c-Abl mediates resistance, whether c-Abl targeting can re-sensitize tumors to cetuximab in a clinical trial and if AXL and c-Abl association can serve as a biomarker to predict cetuximab resistance in HNC.